Trajectory of epigenetic aging and health outcomes in childhood cancer survivors

ABSTRACT
Survivors of childhood cancer are at increased risk for chronic health conditions (CHCs) and early mortality at
rates typically among individuals decades older, suggesting an accelerated aging phenotype. However, there
are limited studies applying molecular biomarkers to quantify the acceleration of aging in long-term survivors of
childhood cancer. Here, we propose to apply epigenetic age to measure biological aging and investigate the
trajectories of epigenetic aging, risk factors and health outcomes in this population. Our proposal is built upon
our previous studies reporting that that epigenetic age acceleration (EAA) is significantly higher in survivors of
childhood cancer than individuals without a history of cancer, and is associated with treatment exposures,
unfavorable health behaviors, and presence of CHCs. To further our research, we will take advantage of the rich
resources of the St. Jude Lifetime Cohort Study (SJLIFE), which includes 4,263 5+ year survivors of childhood
cancer who have been characterized with genome-wide epigenetic profiling (MethylationEPIC BeadChip) using
peripheral blood mononuclear cells (PBMCs) collected at one time point (T1), and are well documented for cancer
treatment exposures, health behaviors, social determinants of health (SDOH) as well as comprehensive clinical
assessments of CHCs. We will also measure EAA for a set of 1,804 survivors with PBMCs collected at a second
time point (T2) and 1,000 survivors for a third time point (T3), with an interval of approximately 5-years between
adjacent time points. In addition, we will leverage two ongoing NIH-funded intervention trials: Telehealth-based
intervention to improve fitness [CA246570], and eHealth intervention for late effects of childhood cancer
[CA239689], where biospecimens will be collected before and after the intervention and will undergo epigenetic
profiling. The overarching goals are to: 1) examine the effect of health behaviors and SDOH factors on the rate
of change in EAA during follow-up of the SJLIFE cohort; 2) evaluate the association between the rate of change
in EAA and subsequent long-term outcomes including prevalence/severity/cumulative burden of CHCs and
mortality during follow-up of the SJLIFE cohort; and 3) determine the impact of behavioral interventions for
physical fitness and sleep quality on the changes in EAA. Our novel study will encompass observational and
interventional components, each with a longitudinal repeated measures of EAA at up to three time-points to
enable evaluation of the changes in EAA. Findings from non-Hispanic White survivors will be evaluated in diverse
populations including non-Hispanic Black and Hispanic survivors as well as non-cancer controls in an exploratory
fashion. Successful completion of the proposed study will substantially advance our understanding and generate
new insights into the accelerated aging phenomenon, inform development of novel interventions to slow down
accelerated aging and prevent or remediate age-related CHCs, and facilitate future clinical translation of EAA
and/or other aging biomarkers to patient care, which is critically needed for aging survivors of childhood cancer.

Public health relevance
RELEVANCE Survivors of childhood cancer experience accelerated aging with high burden of chronic health conditions (CHC) and premature mortality, hence it is critical to conduct proposed clinical aging research in this vulnerable population to improve survivorship care and quality of life for these individuals. In the current proposal, we will leverage preexisting epigenetic profiling data, and also generate additional epigenetic profiling data from stored biospecimens collected during the longitudinal follow-up of our well-established cohort of childhood cancer survivors, as well as from samples collected during two ongoing health promoting behavioral intervention trials. We will investigate how social determinants of health and health behaviors will affect the change of epigenetic age acceleration (EAA) among survivors of childhood cancer, and how the change in EAA will subsequently influence long-term health outcomes, and explore the effect of health promoting behavioral interventions on EAA and if the change pattern of EAA portends the improvement of targeted health outcomes.